Structure and function of cloverleaf RNA in enterovirus

Abstract
Human enteroviruses are responsible for diseases that range from mild conditions like the common cold
to severe diseases such as poliomyelitis and myocarditis. For example, the inflammation and weakening of the
heart muscle (myocarditis) caused by coxsackie B3 virus (CBV3) can lead to heart failure. Approximately 10-15
million people are infected with enteroviruses in the US each year, yet no antiviral therapies are currently
available. Our long-term goal is to obtain detailed structural and biochemical information regarding the
enterovirus replication process, and to use this information for the development of antiviral therapeutics and
vaccines. In enteroviruses and other positive-strand RNA viruses, the RNA genome is used as a template for
both protein translation and RNA synthesis, and thus these viruses need a mechanism to balance the relative
extents of these two processes. Enteroviruses use a ‘cloverleaf’ four-way junction RNA structure at the 5’ ends
of their genomes to serve as a binding site for the host protein, poly(rC)-binding protein 2 (PCBP2) and the virally
encoded protein 3CD, and to modulate the relative levels of viral protein translation and RNA genome synthesis.
The goal of the project is to understand how the cloverleaf RNA interacts with these host and virus proteins to
balance protein translation and genome synthesis to ensure efficient replication. To accomplish these goals, we
will determine the structure of 5’ cloverleaf of the coxsackie virus genome and characterize its interactions with
PCBP2 using complementary structural, biochemical, and biophysical approaches. The structure of cloverleaf
is predicted to be conserved in enterovirus, rhinovirus, and other picornaviruses, and hence our studies will
inform how the 3D structure of cloverleaf RNA regulates viral replication in this large class of viruses.

Public health relevance
PROJECT NARRATIVE (RELEVANCE) Enteroviruses such as coxsackie virus infect about 10 to 15 million people each year in the United States, yet no antiviral therapeutics are available. To understand how enterovirus balances viral protein synthesis and genome replication, we will determine the structure of the viral RNA promoter and its essential interactions with a regulatory host protein. The results of this work will lay the foundation for the development of novel antiviral therapeutics to treat these currently incurable infectious diseases.